Small Molecule Activators of Procaspases as Anti-Cancer Agents

The overexpression of procaspase-3 (PC-3) in diverse tumor types presents an exploitable weakness in
cancer and an opportunity for selective induction of apoptotic death in cancer cells. This proposal is a
renewal of R01-CA120439, whose major goals included the investigation of the potential of the PC-3
activator PAC-1 in the treatment of glioblastoma (GBM) and metastatic osteosarcoma. These past four
years have been very successful and as a result of these studies PAC-1 is now in a single-agent Phase 1
clinical trial (for late stage human cancer patients) and a combination clinical trial (for human glioblastoma
patients), with other trials to being in 2018. Our work has shown that PAC-1 treatment, through activation
of PC-3 to caspase-3, can induce cleavage of key caspase-3 substrates in cancer cells, leading to
pronounced synergy with certain anticancer drugs. In the proposed work we will identify the most promising
PAC-1/drug combinations for the treatment of Grade II/III meningioma, taking advantage of a key feature of
PAC-1 (its blood-brain barrier penetrance) and utilizing our novel translational pathway (evaluation in pet
dogs with meningioma). We have also found that PAC-1 markedly synergizes with drugs that hit targets in
the MAPK pathway, due to the ability of PAC-1 to induce cleavage and inactivation of MEK1 and MEK2.
This discovery will be explored through investigation of PAC-1 combinations in non-small cell lung cancer
models, utilizing mouse models of metastases to the CNS. Finally, based on known caspase-3 substrates
and preliminary data, we hypothesize that PAC-1 will have considerable mechanism-based synergy with
immune checkpoint inhibitors through the facile cleavage and inactivation of the protein MLH1 by caspase-
3. Logical extension of this data would suggest that such mechanism-based synergy with PAC-1 could lead
to immune checkpoint inhibitors being active in a much higher percentage of cancer patients, an exciting
possibility. This is a hypothesis-driven proposal with high potential for fundamental and translational impact.

Public health relevance
There is a lack of effective targeted therapies for many deadly cancers, and even those that are available typically provide only a modest benefit due to inevitable resistance. We have identified the overexpression of procaspase-3 as an exploitable defect in cancer, and we have discovered a compound (called PAC-1) that activates procaspase-3 and selectively induces apoptosis in cancer cells. We now seek to use the synergistic activity of PAC-1 and our innovative translational path to identify outstanding PAC-1/drug combinations that can be advanced for the treatment of deadly malignancies.